Assessment of the Precision Medicine Analysis and Coordination Center (PMACC)

The primary objective of this project is to perform an assessment and evaluation of the Precision Medicine Analysis and Coordination Center (PMACC)’s current functionality and technical implementation against the desired end state and requirements for the current and upcoming studies.